EVALUATION OF ADVERSE ALLERGIC REACTIONS TO VACCINES

Influenza vaccine is recommended for asthmatics regardless of age. Recent correspondence in Lancet indicates some concern among physicians of the safety of administering influenza vaccine to asthmatics. A review of FDA AERs will be carried out to evaluate the frequency of allergic/asthmatic reactions following influenza immunization.